RNA helicases to combat RNA phase transitions in repeat expansion disorders

Abstract
Repeat-expansion disorders are a collection of more than 40 rare but devastating diseases that largely effect
the central nervous system. Currently, they are incurable. The genetic basis for these disorders is repeat
expansions, the length of which determines disease severity and age of onset. In these disorders, repeat
sequences cause pathology in a multimodal fashion. The translation of repeats located in coding regions can
disrupt normal protein function and produce toxic repeat peptides. These neurotoxic peptides can be produced
even when the repeats are in noncoding regions via repeat associated non-AUG translation. Another agent of
pathology is the repeat RNA transcript itself, where aberrant binding of the repeat RNA to RNA-binding proteins
leads to issues like deregulation of the miRNA machinery, aberrant translation, and mis-splicing events. Repeat
RNAs also enable transcripts to undergo liquid-liquid phase separation (LLPS) and form nuclear RNA foci in
cells. These foci can sequester RNA-binding proteins, which may contribute to the observed repeat RNA toxicity.
It has been well established that RNA helicases regulate the formation of phase separated ribonucleoprotein
(RNP) granules in cells, but no work exists to understand how helicases affect the RNA foci in repeat-expansion
disorders. Considering first that repeat RNAs cause potentially pathological RNA foci and that second, helicases
are important for the formation of other cellular RNP granules, we hypothesize that RNA helicases can also
modulate the formation of RNA foci in repeat-expansion disorders. The proposed work is focused on the
deleterious RNA foci that form in the repeat-expansion disorders caused by CAG trinucleotide expansions like
Huntington’s Disease and several spinocerebellar ataxias. This proposed study aims to identify RNA helicases
that modulate these deleterious RNA foci and understand the mechanism by which they do so. Knockout screens
in human HAP1 cells expressing CAG repeat constructs which form RNA foci have identified candidate RNA
helicases that affect RNA foci size and number. This work will utilize in vitro approaches to understand the
mechanism underlying how these candidate helicases effect RNA foci. After the recent failure of two candidate
therapies for Huntington’s Disease in clinical trials, it is especially necessary to consider new therapeutic targets
for these disorders. This work will expand our understanding of RNA helicase function in repeat-expansion
disorders and offer a new therapeutic tool to explore for combatting these diseases.
The proposed fellowship will be conducted at the University of Pennsylvania in the lab of Dr. James Shorter, a
leading researcher in the molecular basis of neurodegenerative diseases and protein disaggregases. Completion
of the proposal in this lab will provide rigorous training in biochemical assay design and in vitro protein and RNA
handling techniques.

Public health relevance
Project Narrative This proposal aims to identify and characterize the RNA helicases that affect deleterious nuclear RNA foci that form in repeat expansion disorders. Repeat expansion disorders, like Huntington’s Disease and spinocerebellar ataxias, are devastating diseases of the central nervous system that are currently incurable. Determining how RNA helicases directly affect an aspect of disease pathology will provide essential insight into the molecular basis of repeat expansion disorders and perhaps offer new therapeutic targets for future treatments.